University of California Berkeley Chemistry-Biology Interface Training Program

PROJECT SUMMARY
This is the third renewal application for the Chemistry-Biology Interface predoctoral training grant
at UC Berkeley. The program provides graduate PhD students with a unique depth of training in
the application of chemical principles and techniques to the investigation and modulation of
biological systems. The program’s goal is to encourage further integration of the fields of
chemistry and biology and prepare students for a future of research at this interface. Key
components of the program include three first-year laboratory rotations among 41 faculty in nine
different departments, specialized didactic training, seminars, annual retreat and career day, and
new in this proposal, enhanced professional and career development programs, expanded
training in scientific communication, and a new academic-industrial partnership in translational
chemical biology with Novartis International. To date, the program has trained over 180 students
with 99 already completing their PhD degrees, 57 during the last grant cycle. Students emerging
from Berkeley with this unique training are positioned to make a significant impact on human
health and biomedical science in both industrial and academic settings.

Public health relevance
PROJECT NARRATIVE This proposal trains students to develop competence at the intersection of chemistry and biology fields. Students learn the language and techniques to manipulate biological systems at the molecular level, which is key for the design of rational means of diagnosis and treatment of pathological processes. Reciprocally, the study of biological problems leads to the development of new synthetic and mechanistic tools in the chemical sciences. Students trained in this interdisciplinary program are uniquely positioned to make new discoveries in biomedical science and craft new cures for human disease.